Photodynamic Alteration of Cell Membrane Lipids to Enhance Chemotherapy Efficacy in Metastatic Ovarian Cancer

PROJECT SUMMARY
High-grade serous ovarian carcinoma (HGSOC) manifests with peritoneal metastases in over 75% of patients.
Despite aggressive treatment, including cytoreductive surgery and platinum-taxane chemotherapy, the
remaining metastases almost inevitably give rise to chemoresistant recurrences for which no curative treatments
exist. There is an urgent need for complementary strategies to address resistance in these residual tumors.
Altering cell membrane lipid composition has emerged as one such strategy. This proposal aims to utilize
photodynamic alterations of cell membrane lipids to promote chemotherapy penetration and efficacy in preclinical
models of peritoneal metastases. This will be achieved by combining two clinically viable approaches: 1) Co-
delivery of easily oxidizable polyunsaturated fatty acids (PUFAs) with lipophilic photoactivatable molecules
(photosensitizers) and 2) Induction of lipid peroxidation within cancer cell membranes that occurs downstream
of photochemically-generated reactive oxygen species (ROS)—photodynamic priming (PDP). This approach is
based on a hypothesis that lipid pathology initiated by incorporating PUFAs into membrane-forming
phospholipids, followed by exposure to photochemically-generated ROS, will synergistically “prime” cells for
subsequent chemotherapeutic eradication. Intraperitoneal light delivery, proven feasible in University of
Pennsylvania trials, allows integration of the proposed strategy within the current standard of care. In this
approach, PUFA and photosensitizer would be administered prior to cytoreductive surgery, during which light-
irradiation would photodynamically alter cell membranes to enhance response to postoperative chemotherapy.
During the mentored K99 phase, Dr. Overchuk will investigate the effects of free PUFA, PDP, and combinations
on carboplatin efficacy in orthogonal models of HGSOC. As a clear path to independence, Dr. Overchuk will
develop a lipoprotein-mimetic nanoparticle to harness natural lipid trafficking mechanisms for codelivery of
PUFAs alongside a photosensitizer. Upon her transition to the R00 phase, Dr. Overchuk will compare PDP using
free versus nanoencapsulated PUFAs and photosensitizers with respect to tumor selectivity and carboplatin
enhancement. A mentoring committee will guide Dr. Overchuk’s research and facilitate her transition to
independence. As primary mentor, Dr. Imran Rizvi will train Dr. Overchuk in physiological models of HGSOC
peritoneal metastasis. As co-mentor, Dr. Alexander Kabanov will provide specialized training in nanoformulation
development. Drs. Robert Chapkin (PhD), Victoria Bae-Jump (MD/PhD) and Huang Chiao (Joe) Huang (PhD)
will bring further expertise in membrane therapies, lipid metabolism, clinical management of HGSOC and
translational photomedicine. To summarize, this proposal aims to address key barriers to treating peritoneal
metastases with a mechanistically distinct approach and establish a cancer-agnostic platform translatable to a
wider variety of malignancies. The mentorship provided by this K99/R00 Award will allow Dr. Overchuk to pursue
this clinically relevant research and enable her transition to an independent career.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Over 75% of ovarian cancer patients are diagnosed at late stages with peritoneal metastases, and while surgical resection and chemotherapy can diminish this metastatic burden, the residual cancer cells often lead to chemoresistant relapses without available curative treatments. This proposal aims to augment the effectiveness of standard chemotherapy by modifying tumor cell membrane composition using light-activated nanotechnologies capable of carrying easy-to-oxidize lipids. If successful, this approach could form the basis of a complementary treatment paradigm, capable of integrating within current standard of care and broadly applicable to a wide variety of advanced-stage malignancies.